Scientific Information Management and Literature-Based Evaluations for the DTT - Support for Systematic Review Activities on Personal Care Products

The Division of Translational Toxicology performs systematic reviews of literature to assess the potential for adverse effects on human health by agents, substances, mixtures, or exposure scenarios, based on information about human exposure. The findings of these reviews are generally focused on either cancer or non-cancer effects and published as monographs or manuscripts. The systematic reviews on personal care products are focused on fetal growth and puberty endpoints and are being conducted in support of the Health Assessment and Translation Group, who conducts literature-based assessments of non-cancer health effects. Keywords: systematic review, toxicology, epidemiology, exposure, non-cancer effects.